UT Southwestern Advancement of Neuroscience Research Careers (UT SWANS)

PROJECT SUMMARY/ABSTRACT
The UT Southwestern Advancement of Neuroscience Research Careers (UTSWANS) program promotes the
development of future clinician-neuroscientists. The program is available to talented clinical residents and
fellows in Neurology (adult and pediatric), Neurosurgery, and Neuropathology. Participants in UTSWANS
receive a structured plan for integrating research activities as well as research education and mentorship into
their clinical training. This goals of the program are to attract and encourage talented neuroscience clinicians
toward a career as physician-investigators and to increase the likelihood that these individuals will succeed in
obtaining initial independent funding for their research. UT Southwestern is an excellent environment for this
training program. In the first cycle of funding, UTSWANS has been successful with its first participants and has
a growing pipeline of potential participants. We have made refinements in the training plan and administrative
structure of the program to further strengthen recruitment, to leverage resources and opportunities that are
available to trainees through the O’Donnell Brain Institute and expanded the number and diversity of potential
research mentors.

Public health relevance
PROJECT NARRATIVE The development of clinician-scientists in the neurosciences is critical for future advancements in the care of patients with neurological disorders. This research training program provides support for physicians in clinical training so they can engage in neuroscience research. It provides protected time, mentorship, education and experience in research as the first steps toward a successful career for physician-scientists.